Culturally Competent, Ethical, and Empathetic AI Police E-Trainer for Improving Non-Lethal De-Escalation Skills in a Multi-User Virtual Reality Environment to Mitigate Murders Against Black Males.

PROJECT SUMMARY/ABSTRACT
Police violence against black males, in the United States (U.S.), is a public health disparity [37]. Physical &
psychological violence that is structurally mediated by systems of law enforcement, results in deaths, injuries,
trauma, and stress that disproportionately affect blacks in the U.S. According to a 2019 study, published in the
Proceedings of the National Academy of Sciences, Americans’ risk of being killed by police is highest for black
men, who face ~1 in 1,000 chance of being killed by police over their lifetime. White men have ~1 in 2,500
chance of being killed by police over their lifetime, and Latino men a ~1 in 1,900 chance. Women less likely than
men to be killed by police. Their lifetime risk is ~1 in 33,000, compared to 1 in 2,000 for men. Moreover, black
men, in the U.S., are up to 3.5 times more likely than whites to be killed by law enforcement; and 1 in every
1,000 black men will die at the hands of police. In Baltimore, Maryland (MD), The Department of Justice (DOJ)
revealed, in a 163 page report, that African Americans were targeted and abused by Baltimore police indicating
a conspiracy against black citizens. The Center for Disease Control and Prevention (CDC) estimates the overall
cost of fatal and nonfatal injuries, by law enforcement, is ~$1.8 billion including medical costs and work lost.
Public health policy experts suggest that mandatory training shall be implemented to reduce implicit bias of
law enforcement officers against communities of color. However, little is known about effects of implicit biases
on behavior, and no experimental studies have been conducted to measure the impact of implicit bias reduction
interventions among law enforcement officers. Likewise, officers receive limited de-escalation training;
w/training efforts met w/ resistance from police chiefs & national Fraternal Order of Police.
During the NIH SBIR Phase 1 effort, Juxtopia team will address aforementioned public health disparities to
help mitigate police violence endemic against black males by investigating the technical/commercial feasibility
of engineering Juxtopia® CAMMRAD Police De-escalate Virtual Reality (VR) simulation to distribute an
artificial intelligent (AI) police e-trainer & e-evaluator, “BES” built on the Juxtopia® Context-Aware Mobile
Mixed Reality Assistive Device (CAMMRAD) platform to achieve the following SBIR Phase I Specific Aims.
A. Prototype CAMMRAD Police De-Escalate VR e-train/e-evaluate police on de-escalation skills in VR.
B. Evaluate CAMMRAD Police De-Escalate VR w/ police in VR scenarios known to lead to escalation.

Public health relevance
PROJECT NARRATIVE The objective of the proposed NIH SBIR Phase I research and development (R&D) effort is to address the public health endemic of police murders against black males by improving police training with an innovative artificial intelligent (AI) enabled Juxtopia® CAMMRAD Police De-Escalate Virtual Reality e-training simulation. Specifically, the Juxtopia® AI police educator, “BES” (i.e., Ancient Egyptian God of Domestic Protection) will autonomously e-train and e-evaluate police trainees on culturally competent, ethical, and empathetic de-escalation skills using non-lethal force within a multi-user and interactive VR simulation; built upon the Juxtopia® Context-Aware Mobile Mixed Reality Assistive Device (CAMMRAD) VR software platform.